Short-term biomedical research training program for veterinary students

ABSTRACT
The objective of this professional student short-term research training grant is to provide predoctoral training
opportunities to 14 veterinary students annually who have completed their first or second year with
immersive experiential learning by carrying out mentored biomedical research, enriched by seminars and
events that are designed to inspire them for careers combining their medical training and research. The goal
of the program is to capture the enthusiasm and imaginations of DVM students early in their training to prime
their appreciation and capacity for basic and translational research. Students will be engaged in hypothesis-
driven discovery and problem-solving research in a high-quality laboratory setting for 12 weeks during the
summer. Only the most outstanding researchers/mentors from have been included as trainees in the
proposed research training program. Participating faculty have been grouped into the following areas of
research excellence: 1) Antimicrobial Resistance and Microbial Pathogenesis, 2) Vector Borne Diseases
and Disease Ecology, 3) Immunity and Immune Modulation 4) Airway Biology and Disese 5) Comparative
Toxicology and 5) Animal Models, Sponaneous Diseases in Animals and Translational Studies, serving as
convergent foci. A week long orientation program, and special events have been designed to guide the
students for success in this experiential learning opportunity. Training in responsible conduct of research
and data reproducibility and reliability are integral parts of the program with special sessions and
seminars reinforcing these principles. Recruitment efforts planned are directed not only to DVM students in
our college, but to veterinary students from other U.S. colleges of veterinary medicine and are designed to
ensure that students underrepresented in the biomedical sciences have access to this research experience. All
students participating in the program are required to present their research results at the annual College of
Veterinary Medicine Phi Zeta Research Day, and encouraged to present at the National Veterinary Scholars
Symposium and other national professional meetings, and to publish their work with their mentors, as
appropriate. Increasing our human capital in veterinary scientists is critical to the protection of public health and
advancement of science that benefits animals and humans, both as individuals and as populations.
Summer research experiences provide a critical step into the research enterprise to the veterinary students
early in their training and foster interest and develop aptitude for further training in the biomedical
sciences, serving as a steping stone for research intensive careers as biomedical scientists.

Public health relevance
NARRATIVE To meet the national need for veterinary scientists to guard and improve human health through biomedical research, we propose a plan to provide experiential training in research to veterinary students early in their medical training through immersion in research during the summer months of their first or second year of veterinary training. Students will learn about responsible conduct of research, data stewardship and engage in mentored biomedical research which will capture their excitement and prepare them to pursue careers in research in multi-disciplinary teams to solve important problems in human health. The mentored training provided through this program will lay a strong foundation for further contributions by the trainees throughout their careers.